Enhancing the Efficiency of Data Collection for Surgical Quality Improvement

Background: Although the majority of national quality initiatives utilize electronic health record (EHR) or
administrative data, their ability to adequately discriminate performance has been brought into question and it
is unclear certain outcomes, such as postoperative complications, are accurately ascertained. By comparison,
clinical registry data, like the VA Surgical Quality Improvement Program (VASQIP), are widely considered
robust for performance evaluation and quality improvement (QI). But, VASQIP data collection is resource
intensive—data are manually abstracted by trained local Surgical Quality Nurses (SQNs) for a systematic
sample of surgical cases performed at all VA hospitals. VASQIP then uses the data to characterize the quality
and safety of surgical care at each hospital based on risk-adjusted 30-day morbidity and mortality rates.
Significance: VASQIP data collection practices present two important limitations. First, perioperative
outcome rates have significantly decreased the past two decades making it unclear whether systematic case
sampling is adequately powered to identify underperforming hospitals. Second, the time required for VASQIP
data collection detracts from SQNs’ ability to engage in other important job functions, like local QI activities.
Because SQNs spend substantial time working with VASQIP data, this represents an important missed
opportunity to identify a quality problem when it is evolving rather than when it has already occurred. As such,
alternative approaches that can provide reliable data and decrease the burden of data collection would have
tangible benefits for other national surgical and non-surgical QI initiatives within VA and the private sector.
Innovation: This project is novel because it can change the paradigm regarding the collection of QI data from
purely EHR or clinical registry to a more efficient hybrid model that could address reliability concerns
associated with the use of EHR (or administrative) data alone. It will also provide real-world, generalizable
data that can only be obtained within VA's data platform and can inform VA and the private sector national
surgical and non-surgical QI initiatives. We have two national operational partners: 1.) VA National Surgery
Office (NSO); 2.) Office of Reporting, Analytics, Performance, Improvement, and Deployment (RAPID).
Specific Aims: The overall goal is to address two important questions. First, given low perioperative
outcome rates across VA, is systematic sampling robust enough to inform surgical QI? Second, are hybrid data
(i.e.: EHR combined with clinical registry variables) a potentially reliable alternative for measuring VA
hospital surgical performance? These questions will be explored through the following specific aims: (1)
Evaluate whether analyzing all VASQIP-eligible surgical cases, relative to current systematic case sampling,
improves negative predictive value (i.e.: decreases false negative rates) for identifying VA hospitals with outlier
performance; (2) Compare the use of hybrid EHR and clinical registry data, relative to clinical registry alone,
for evaluating risk-adjusted surgical performance at VA hospitals; (3) Explore how more efficient VASQIP data
collection could enhance local QI efforts through in-depth, key informant interviews with SQNs.
Methodology: This mixed-methods proposal will involve hospital-level, observational studies using VASQIP
and Corporate Data Warehouse (CDW) data from patients who underwent non-cardiac surgery (2016-2019) as
well as qualitative interviews with SQNs. With comparative effectiveness in mind, these data will be used to
explore what would be observed if data from all surgical cases were included in VASQIP and to understand
whether other existing VA data sources might improve VASQIP data collection efficiency and enhance local QI.
Next Steps: With the NSO, we will prospectively compare the fidelity of hand-abstracted variables to
automatable variables from CDW. The implementation plan (supported by the VA National Director of
Surgery) will utilize VASQIP’s existing infrastructure by partnering with VINCI to provide the NSO with
centralized CDW access (using RAPID’s data access model as a template) allowing automated data collection.

Public health relevance
Electronic health record (EHR) and clinical registry data are commonly used for monitoring hospital surgical quality. Clinical registry data, like the VA Surgical Quality Improvement Program (VASQIP), are robust because they are hand abstracted by trained personnel, but the time and costs associated with data collection limits hospital performance evaluation to only a sample of all cases performed. Hybrid data (i.e.: EHR combined with clinical registry variables) is an alternative that could increase the number of cases used for measuring hospital performance (providing a more comprehensive picture of the quality of surgical care) and lower the burden of data collection for quality improvement. This mixed-methods proposal will evaluate the reliability of VASQIP’s current case sampling strategy for identifying outlier VA hospitals, explore the use of hybrid data as a means of enhancing data collection efficiency, and will identify how more efficient data collection could enhance local QI through semi-structured interviews with Surgical Quality Nurses.